Regulation of Lipolysis by Oxytocin

ABSTRACT
Adipose tissue lipolysis is a critical process that provides nutritional substrate to other organs
during periods of fasting. Lipolysis also contributes to the metabolic pathology associated with
obesity, as lipid species from adipose tissue promote hepatic glucose production and are also an
important contributor to the excess fat seen in nonalcoholic fatty liver disease. Despite the
importance of lipolysis in mammalian physiology and pathophysiology, there is still much to be
learned about how it is regulated and what its consequences are. There have been reports over
the years that the neuropeptide oxytocin (Oxt) is an inducer of lipolysis. Our preliminary data
corroborates this, but goes much further in several important areas. First, we show that Oxt
signaling is not only required for normal lipolysis in the setting of fasting and cold exposure, but
is also needed for b-adrenergic agonists to exert their well-known pro-lipolytic effects. We also
identify the relevant source of Oxt as a subpopulation of TH+ sympathetic neurons innervating
white adipose depots. In this proposal we intend to fully characterize the intracellular signaling
pathways by which Oxt promotes lipolysis. In addition, we will determine the local mechanism by
which Oxt levels are controlled through degradation. Finally, we will follow up on preliminary data
suggesting that maternal Oxt signaling in fat is required to ensure milk of proper nutritional content
during lactation. Taken together, these studies will greatly advance our understanding of lipolysis.
Furthermore, Oxt is being pursued as a pharmacological therapy for a variety of conditions,
including anxiety and neurodegenerative disorders, and this work will provide important
information about potential metabolic side effects.

Public health relevance
NARRATIVE Oxytocin is best known as a hypothalamic hormone that controls parturition and lactation, but there has been recent interest in novel roles for oxytocin in metabolic physiology. In particular, we have shown that oxytocin is a critically important regulator of lipolysis—the breakdown of triglycerides into fatty acids and glycerol—in adipocytes. Here we propose to determine how oxytocin carries out this function at the cellular level, how oxytocin levels are regulated in the fat pad, and whether oxytocin-mediated lipolysis is a key contributor to the nutritional content of mother’s milk.